Metabolic Regulation of Pancreatic Epithelium Development

Project Summary/Abstract
Immediately after fertilization, metabolism in the early embryo undergoes drastic remodeling. While studies
have thoroughly characterized pre-implantation embryonic development, measurements of metabolism in the
embryo post-implantation, from gastrulation to birth have been limited by scarcity of tissue and inaccessibility
of the embryo. in vitro differentiation of human embryonic stem cells provides an unlimited source of tissue and
a platform to study the metabolic transitions that occur within the rapidly expanding embryo. Using directed
differentiation of human embryonic stem cells into pancreatic epithelium, this proposal aims to combine
metabolic interrogation of cell proliferation and biomass accumulation with developmental biology. These
studies will blend recent conceptual advances in cancer metabolism with an in vitro differentiation platform to
understand how metabolism instructs and directs cell fate decisions in the developing fetus.
Experiments will first focus on cellular redox state, testing whether changes in NAD+/NADH ratio as human
embryonic stem cells undergo differentiation into pancreatic epithelium are necessary to support differentiation
into the pancreatic lineage. Then, kinetic tracing studies using isotopically labeled nutrient sources will quantify
rates of metabolic flux to determine how changes in overall metabolism contribute to differentiation. Finally,
metabolites that have been identified to undergo large fluctuations in abundance throughout differentiation will
be studied to determine whether their accumulation is necessary for successful pancreatic differentiation.
This proposal is designed to explain the roles of metabolism in the developing pancreas as it continuously
differentiates and expands in a changing nutrient environment. Results from each of these aims can be used to
improve in vitro differentiation of stem cells by providing new mechanisms to guide successful differentiation
into a desired cell type. By providing new insight into metabolic regulation of stem cell fate, this work will
enhance the ability to generate curative stem cell-based therapies for patients suffering from lost or dysfunctional
tissues, especially type 1 diabetes. These therapies hold great promise for improving health and quality of life for
millions of patients.
These experiments will be carried out in the laboratory of Professor Matthew Vander Heiden within the Koch
Institute for Integrative Cancer Research at Massachusetts Institute of Technology. Training under this
fellowship will include presentation of this data at institutional and public conferences, publication of this work
in peer-reviewed scientific journals, and regular meetings with professor Vander Heiden to prepare the applicant
for success as a tenure track research faculty member.

Public health relevance
Project Narrative The goal of this work is to define how cellular metabolism supports and regulates the ability of stem cells to undergo successful differentiation. This proposal utilizes the stepwise, directed- differentiation of human embryonic stem cells into pancreatic epithelium as a model to study the metabolism of human development. Results of this work will provide novel approaches to induce differentiation of cell types of interest from pluripotent stem cells by selectively supporting their growth, and improve our ability to produce stem cell-derived human tissues useful for cell therapies and modeling human disease.